High Signal-to-Noise Ratio Miniature Microphones for Hearing Assistive Devices

High Signal-to-Noise Ratio Miniature
Microphones for Hearing Assistive Devices
Project Summary
Hearing impairment is associated with a loss of fidelity to quiet sounds, while the threshold of pain remains the
same. As such, hearing impairment causes a loss of dynamic range or “window” of detectable sound amplitudes.
Directional sensing enables preferentially amplifying desired sounds without amplifying background noise. In
modern hearing aids directional sensing is achieved with closely spaced microphone arrays. When the array
aperture is small compared to the wavelength of sound, as is the case for a broad range of frequencies relevant
to hearing aids, directivity is achieved by subtracting microphone signals with only a small relative phase
difference. The resulting signals are small, and high SNR from the directional system demands high signal-to-
noise ratio (SNR) from individual microphones. Capacitive microphones have undergone two decades of
optimization and their SNR has plateaued. On the other hand, thin-film piezoelectric materials and related
processing technologies are improving at a fast pace owing to their relevance to a wide range of Health and DOD
applications. Single-crystal lithium niobate (LN) has recently been identified to have remarkably high sensing
figures of merit when the electric field is measured in-plane and along the same axis as the induced stress, known
as lateral field transduction. Recent advances in wafer processing have made in-plane polarization and lateral
field transduction practical for micromachined bimorph LN diaphragms. Preliminary simulations of LN
microphones accounting for dielectric loss and relevant packaging-induced noise predict that 7 dB improvement
in SNR beyond state-of-the-art miniature hearing-aid microelectromechanical system (MEMS) microphones is
possible. This improvement directly translates to 7 dB hearing-aid system SNR improvement when operating in
directional mode. 7-dB hearing-aid system improvement is anticipated to have a significant positive impact on
patient perception and intelligibility when hearing in noise. This STTR Phase 1 entails many challenges, including
microfabricating the envisioned microphone die, piezoelectric material characterization of this new material in
the audible frequency band, packaging into industry-standard size capsule, rigorous characterization of noise,
SNR, and acoustic frequency response of the packaged microphone.

Public health relevance
Project Narrative Microphones with high SNR are an important subsystem of hearing aids, and microphone SNR is particularly important for hearing-in-noise applications. This R21 exploits recent innovations in piezoelectric materials and related processing capabilities to explore a microphone with anticipated SNR of more than 2x the current state of the art.